Causal and Event Based Modeling of Brain Alterations in ADRD

ABSTRACT -
More than 1 in 9 seniors in the United States is living with Alzheimer’s disease (AD), and the number of people
affected is expected to double over the next two decades, rising to 13 million in 2050 (Alzheimer’s Association,
2022). The recent shift to creating a biological definition of Alzheimer’s disease for research purposes-
advocated by the NIA and the U.S. Alzheimer’s Association task force, has led to great interest in
neuroimaging and other biomarkers of brain health from MRI and PET. While emerging treatments may resist
cognitive decline by 25-37%, there are risks for severe side effects. Efforts to identify precise markers of
disease progression in the living brain as early as possible are essential. Furthermore, knowing if, how, and
when the early deviations can be adjusted through modification of lifestyle factors can be essential in
preventing decline. Unfortunately, many efforts to track AD reduce the rich biomarker information available in
neuroimaging to a single metric - hippocampal volume or amyloid positivity. The vast richness of brain wide
data is often overlooked and the temporal sequence of biomarker changes is often ignored when evaluating
each risk or resistive factor. We lack causal models of the biomarker changes, to identify modifiable factors in
our lifestyle or genome that could resist or delay the onset of the disease, or guide treatment selection, even in
the presence of confounding factors. Here we address these gaps in the AD research field with a multi-arm
project that seeks to use sophisticated high-dimensional deep learning, event based modeling to elucidate the
spatial rich causal sequence of brain biomarker changes that lead to AD and causal factors that influence
them. We have 3 Specific Aims: Aim 1) We will fit novel adaptations of multishell dMRI models to more widely
available single-shell clinical dMRI data from multiple independent public datasets to predict CSF and
PET-derived Aβ load in symptomatic vs pre-symptomatic individuals. Aim 2) Use our novel AI models to
generate individualized whole brain MRIs at future time points based on sex-specific normative models,
creating individualized prediction maps like ‘digital twins’ of brain morphology at any age. We expect these to
be more sensitive to identifying abnormal aging trajectories than current full brain methods, and more specific
to disease pathology and risk factors than “brain age” alone. Aim 3) Use our novel marginal sensitivity model
for continuous treatments to identify causal relationships, which are partially robust to confounding, between
modifiable lifestyle factors including specific diet scores and physical activity and brain alterations in key
dementia related neurodegenerative pathways. We will model causal effects and their dependency on age and
sex. We hypothesize that neuroimaging metrics that show associations with earlier pathologic changes,
including microstructure, will be more tolerant to confounding in retaining a causal relationship between
lifestyle and brain integrity. The resulting set of tools will be more inclusive of the rich biomarker data in AD,
offering a means to track its evolution and the causal factors that affect it.

Public health relevance
Narrative Large-scale aging and epidemiological datasets can be harmonized alongside studies specific to Alzheimer’s disease and related dementias to generate computational models that can map normal brain aging and identify the first non-invasive indicators of abnormal brain aging and ADRD pathology and the modifiable lifestyle factors that can potentially alter the course of the abnormalities. Here, we propose advanced modeling techniques of harmonized high dimensional data from existing and public datasets to 1) create normative aging models of the entire brain at the individual level to identify the first signs of deviations at local brain regions; 2) use high dimensional event based modeling and subtyping approaches to identify the order in which different microstructural and structural properties of brain tissue start to deviate from normality in the progression of disease; and 3) use marginal sensitivity analysis to model the extent to which modifications in lifestyle factors may causally relate to changes in trajectories of brain abnormalities in the progression of dementia.